Long noncoding RNA regulation of Atherosclerotic Cardiovascular Disease

SUMMARY
Despite therapeutic advances, cardiovascular disease (CVD) remains the leading cause of death worldwide.
There is thus an urgent need for innovation in CVD research and drug development. One class of molecules
thought to hold particular promise is noncoding RNA, the importance of which was largely unrecognized until the
last decade. The human genome is estimated to encode between 30,000 and 60,000 long noncoding RNAs
(lncRNA), far more than the number of protein coding transcripts, and yet the vast majority remain unstudied.
LncRNAs have been shown to play critical roles in genome organization and orchestration of gene expression
in normal cellular function and disease. Discerning lncRNAs with regulatory functions in cardiovascular health
and disease, and dissecting their molecular mechanisms is a paramount priority, and challenge, for the field.
Using a systems biology approach that relies on human tissues and animal models, clinical data, predictive
bioinformatics and deep molecular phenotyping, we have identified a conserved cis-acting lncRNA, which we
have named CASLR, that is highly expressed in human and mouse atherosclerotic plaques. In this proposal, we
aim to decipher the molecular mechanisms by which this novel lncRNA regulates inflammatory gene expression,
and innate immune responses that drive atherosclerosis progression and ultimately plaque rupture, which can
lead to myocardial infarction or stroke. Our studies will use novel mouse models and innovative 3-dimensional
human vascular explants to test the impact of CASLR inhibition on atherosclerotic inflammation and plaque
burden. Collectively, the proposed investigation into lncRNA CASLR will advance our knowledge of inflammatory
mechanisms of atherosclerotic cardiovascular disease and its complications, and provide foundational studies
for the design of new therapeutic strategies.

Public health relevance
NARRATIVE Cardiovascular disease remains the number one cause of death in the United States. Emerging data indicate important roles for non-coding RNAs in the regulation of inflammation and atherosclerosis, yet this is an understudied area. Our work aims to fill this void by investigating how long noncoding RNAs contribute to cardiovascular disease, with the ultimate goal of identifying novel diagnostic approaches and therapeutic targets for its treatment.